SUBJECT 7 PROOF AUTOMATION TESTING LICENSES

NHLBI / OM / ITAC needs continued use of specialized automated testing software used to comply with established and constantly increasing IT Security requirements. Custom applications and web browsers are to be tested before they are upgraded, patched, or modified, in order to prevent unexpected problems and/or issues with these applications and web browsers once they are upgraded, patched, or modified.
• Subscription for 13 load testing licenses that support up to 100 virtual users
• Subscription for 1 load testing license to support 1,500 virtual users with the option of getting up to 7,500 virtual users